Generation and characterization of a mouse model exhibiting beta-amyloidosis and tauopathy with nuclear depletion of TDP-43

Alzheimer's Disease-Related Dementias (ADRD) is a group of progressive neurodegenerative
disorders with mid to late life onset such as mixed etiology dementias (MED) including Alzheimer's
disease (AD) with TDP-43 pathology. To clarify disease mechanisms and identify therapeutic targets,
a new mouse models that replicate combinations of co-occurring pathological features of human
dementia will be critical. It is well recognized that AD cases with TDP-43 pathology, as compared to
those without, showed a greater decline in cognitive deficits. However, the molecular mechanisms
underlying such contribution of TDP-43 remains elusive. We showed that TDP-43 pathology is due to
loss of TDP-43's nuclear function, particularly its ability to repress cryptic exon splicing, that precedes
formation of TDP-43 cytoplasmic aggregates. That splicing repression is a major role of TDP-43 in
forebrain neurons led us to hypothesize that loss of TDP-43 repression exacerbates neurodegeneration
and cognitive deficits. To address this question, we will take advantage of 1) our model lacking TDP-
43 in forebrain neurons which exhibits age-dependent neuron loss, cognitive deficits and defects in
prelimbic cortical circuits; and 2) our tau model which show, in presence of amyloid plaques, tauopathy-
dependent neuron loss, to develop a novel MED model that would exhibit beta-amyloidosis and
tauopathy along with compromised TDP-43 repression in forebrain neurons, pathological features that
mimic AD with loss of TDP-43 repression. By employing a comprehensive set of molecular,
pathological, neuronal circuit and behavioural/cognitive approaches, we will rigorously characterize the
MED mice across their lifespan, providing a highly innovative and instructive model to clarify disease
mechanism and identify therapeutic targets.

Public health relevance
Alzheimer's disease (AD) with TDP-43 pathology, one of the most common type of mixed etiology dementia (MED) that exhibit amyloid plaque, tauopathy and TDP-43 pathology, showed a greater decline in cognition and brain atrophy as compared to AD without TDP-43 pathology. However, the underlying pathogenic mechanisms remain elusive. In contrast to TDP-43 cytoplasmic aggregates, recent studies in human disease suggest that loss of TDP-43's nuclear function, particularly its ability to repress cryptic exon splicing, may contributes to such exacerbated outcomes, thus providing a strong scientific premise to develop a late life associated mouse model of MED for mechanistic and target identification studies.